Tailoring Stress Cardiac MRI for Women with Ischemic Heart Disease

PROJECT SUMMARY
Ischemia with non-obstructive chronic coronary artery disease (CAD) is more prevalent than obstructive CAD
in women. Veterans in particular, are at higher risk of ischemic heart disease (IHD) due to prevalent non-
traditional (mental illness, Agent Orange exposure, and lifestyle choices) and traditional risk factors, regardless
of sex. Half of patients referred for invasive coronary angiograms have no obstructive CAD, whereas 3 in 4
have coronary microvascular disease (CMD), most of whom are women. Often, CMD passes undiagnosed but
contributes to excess morbidity, health resource utilization, impaired quality of life, and major adverse
cardiovascular events. This is partly because current non-invasive imaging approaches are not specifically
tailored for CMD but were optimized for detection of obstructive epicardial CAD, and invasive coronary testing
is necessary to confirm the diagnosis of CMD. In the past 4 years, our group has focused on a gadolinium-free
stress cardiac MRI approach that overcomes several drawbacks of first-pass perfusion stress cardiac MRI for
women with IHD. We showed that MRI-derived myocardial vasoreactivity and fractional myocardial blood
volume mapping have high specificity as markers of hypoperfusion. Our preliminary results illustrate that MRI-
derived fractional myocardial blood volume mapping has potential to depict the full spectrum of IHD. In this
MERIT renewal, we aim to further target our gadolinium-free MRI approach for CMD by enabling whole-heart
coverage and depiction of coronary morphologic indices. We further propose to develop computational
hemodynamic models that enable patient-specific mechanistic relationships between CMD and IHD to be
studied. Cardiac MRI is attractive for depiction of myocardial IHD in women because it has high spatial
resolution, lacks ionizing radiation, and when coupled with iron-based blood pool agents, imaging in the
steady-state offers higher spatial resolution than is possible with first-pass gadolinium perfusion approaches.
MRI better captures the spatial heterogeneity inherent in the spectrum of IHD. Successful completion of the
proposed work would result in clinical deployment of a comprehensive gadolinium-free cardiac MRI approach
for detection of CMD and a set of methods for in silico estimation of patient-specific coronary hemodynamic
parameters based on imaging targets.

Public health relevance
PROJECT NARRATIVE / RELEVANCE TO PUBLIC HEALTH Ischemic heart disease due to non-obstructive coronary stenosis and small vessel dysfunction (coronary microvascular disease, CMD) is more common than previously thought. The underdiagnosis of CMD and lack of therapeutic options have resulted from our myopic view of obstructive coronary stenosis as the only reason for chest pain and the requirement for invasive coronary testing. We aim to improve the management of CMD by further targeting our high-resolution cardiac MRI framework and developing methods for non-invasive estimation of patient-specific coronary hemodynamic parameters; both will enable detection, monitoring, and testing of therapeutic interventions for CMD.